MINDBOGGLE AUTOMATED ANATOMICAL BRAIN LABELING WITH MULTIPLE ATLASES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. I have developed an automated method for labeling brain MR data called Mindboggle (http://www.binarybottle.com/mindboggle.html), and am presently creating a new version of this software for use by the neuroimaging community.